Loss of mitochondrial NAD+ as a unifying cause of heart failure

Project Summary
Heart disease results in over 650,000 deaths per year in the United States, and nearly half of all adults
are currently living with some form of cardiovascular disease. Currently there is no curative treatment
option except for a heart transplant. Thus, there is significant need for better therapeutic interventions.
Heart failure can take years to develop, but is ultimately characterized by a reduction in cardiac output.
There is a considerable body of research demonstrating maladaptive metabolic reprogramming of
cardiomyocytes at this stage, which contributes to heart dysfunction and adverse remodeling of the left
ventricle. The hypothesis detailed in this application proposes that nicotinamide adenine
dinucleotide (NAD+) deficiency in the mitochondria is sufficient to cause heart failure. Recent
literature demonstrates tissue-level NAD+ decline during ischemic injury. NAD+ precursors have been
found to be therapeutic for heart failure in multiple pre-clinical models. Preliminary data generated in
our lab suggests that the NAD+ precursor nicotinamide riboside (NR) prevented heart dysfunction,
protected mitochondrial function, and improved survival in a model of Friedreich’s Ataxia (FA), in which
mice typically develop progressive hypertrophic cardiomyopathy. This result suggests that NAD+
deficiency may be involved in the pathogenesis of heart failure in FA. Alternatively, it provides preclinical
evidence that NR is therapeutic in FA even without NAD+ deficiency, suggesting that boosting NAD+
levels in the heart tissue can be protective of heart function under mitochondrial stress. To address
these points, this proposal first aims to determine whether low mitochondrial NAD+ levels are observed
with loss of frataxin, and whether increasing mitochondrial NAD+ synthesis with NR ex vivo can directly
support mitochondrial respiration (Aim 1). This proposal also aims to define the metabolic
consequences of mitochondrial NAD+ deficiency in cardiomyocytes, to determine whether
mitochondrial NAD+ loss demonstrates characteristic metabolism of the hypertrophic heart in vivo (Aim
2). Together, this set of experiments will demonstrate whether NAD+ decline is a metabolic
consequence of frataxin loss and mitochondrial damage, and define the importance of mitochondrial
NAD+ maintenance in supporting the normal metabolism of cardiomyocytes. Further, it will provide
mechanistic understanding of the specific action of NAD+ precursors to protect against mitochondrial-
dysfunction mediated heart failure, which will inform future therapeutic interventions in progressive
heart disease.

Public health relevance
Project Narrative The experiments proposed in this project will define the role of the central metabolite nicotinamide adenine dinucleotide (NAD+) in heart failure, informing potential therapeutic interventions in patients. Specifically, this project uses a model of the primary mitochondrial disease Friedreich’s Ataxia (FA) to examine whether NAD+ supplementation can protect against heart dysfunction that is observed in FA, and aims to define the role of NAD+ decline in the pathogenesis of dysfunction observed in heart mitochondria, the ATP-producing organelle inside the cell. Finally, it will demonstrate the specific metabolic consequences of NAD+ loss on the primary cell type in the heart, cardiomyocytes, which will provide evidence supporting the hypothesis that mitochondrial NAD+ deficiency in the heart can result in maladaptive metabolic changes that contribute to heart failure.